Funded extension request for "Expanding recovery support for emerging adults with alcohol use disorder: Training in the science of social network sites"

Project Summary: Principal Investigator (PI), Dr. Brandon Bergman, is seeking a 6th year of salary support at
$142,560 for his K23 to obtain training and conduct mentored research on recovery-related social network
sites and other digital recovery supports. This request includes $100,000 for salary, $32,000 for 32% fringe,
and $10,650 for 8% indirect costs. During COVID-19, the outpatient treatment program from which Dr.
Bergman’s K23 study initially intended to recruit participants transitioned to, and has continued to operate
within, a telehealth-only model. This COVID-related challenge led to insurmountable study recruitment barriers.
Under the guidance of primary mentor John Kelly, Dr. Bergman adapted K23 aims that both a) maintain the
K23’s scope at the nexus of recovery support services and social technology, and b) allow for all study
procedures to be conducted remotely. These studies have been outlined in prior K23 research performance
progress reports (RPPR). In brief, study 1 will examine the utility and phenomenology of participation in
existing, online recovery support meetings (e.g., Alcoholics Anonymous via Zoom) in adults with
moderate/severe alcohol use disorder (N = 60). To promote online recovery support meeting attendance that
can be examined scientifically, we developed a clinical linkage and facilitation that will provide personalized
recommendations across three online meeting types: 12-step, SMART, and All Recovery (an inclusive and
eclectic mutual-help model). Study 2 examines naturalistic, longitudinal effects of online recovery community
participation among individuals "in, seeking, or curious about recovery" who currently use one of two
communities – Intherooms.com or Recovery-related Reddit forums (N = 500). These studies have both been
submitted to our Institutional Review Board (IRB) and are ready to launch pending approval. A 6th year of
salary support for Dr. Bergman would enable him to continue dedicating 75% effort to these studies. Of note,
research funding as initially proposed can be repurposed to carry out Studies 1 and 2. Thus, the PI's salary
support is the only additional funding request being proposed in this supplement. This administrative
supplement is responsive to NOT-OD-21-052 as the request extends beyond merely addressing productivity
issues. The supplement would help to redress barriers to K23 recruitment introduced by the COVID-19
pandemic. In parallel, the additional year of salary support would help to maintain the trajectory of Dr.
Bergman's career development and productivity. Consistent with PA-20-272, the proposed supplement will
redress COVID-19-related barriers to preserve the near-term and downstream impacts of Dr. Bergman's work
on the K23. The supplement will also preserve the likelihood that Dr. Bergman builds a research program
responsive to NIAAA and other NIH priorities. For example, a 6th year of salary support will also provide the PI
with protected time to prepare and submit an R01 application that builds on and leverages data from these K23
studies to develop and experimentally test a digital recovery support service linkage intervention.

Public health relevance
Project Narrative Dr. Brandon Bergman, an early stage investigator, is seeking a funded extension to complete his mentored, NIAAA K23 research that examines the utility of digital, online recovery support services for individuals with alcohol use disorder (AUD) and those in recovery from AUD and other drug use disorders. The supplemental funding would protect 75% of Dr. Bergman's time for an additional year in order to redress study recruitment challenges introduced by COVID-19 (see NOT-OD-21-052). As such, the K23 supplement would help to preserve the likelihood that Dr. Bergman builds a research program responsive to NIAAA and other NIH priorities.